Understanding hydration and stroke outcomes in Zambia

PROJECT SUMMARY A large percentage of patients are dehydrated (more accurately, in a volume contracted state) at the time of stroke, and there is accumulating evidence that these patients do not recover as well as patients who are not dehydrated. Although administering more intravenous fluids may benefit these patients by increasing circulation to the brain, clinicians are often cautious in light of the risks for heart failure and brain swelling which are common after stroke. Application of US guidelines about rehydration strategies after stroke may not be appropriate seen in prior studies of rehydration in pediatric patients with malaria. Furthermore, no information exists about stroke patients with varying comorbid conditions in low and middle income countries like those in sub-Saharan Africa. In order to advance our knowledge, we need to understand the hydration status of stroke patients in Zambia, explore physician perspectives about rehydration in the early stroke period and create regionally appropriate tools to measure stroke outcomes. In this proposal, we seek to demonstrate that simple and broadly available laboratory markers are capable of quantifying a patient’s volume status at the time of stroke and to explore the relationship between volume status and stroke outcomes using tools adapted for use in local Zambian languages. We will additionally conduct focus group interviews with physicians to understand perspectives and current practices in Zambia. Stroke patients from a single hospital in Zambia will have baseline lab testing to assess for dehydration and quantification of stroke severity and functional outcomes over thirty days. We anticipate that the study will establish the clinical relevance of a surrogate composite of labs to identify dehydration in the early stroke period and explore the connection to stroke outcomes in this population. If dehydration is associated with worsened outcomes after stroke, this research will provide the foundation for implementation of a scalable rehydration intervention in future clinical trials. The long-term goal of this study team is to identify potential interventions to improve morbidity and mortality after stroke that are applicable in both resource-rich and resource-limited settings. This research will provide critical data about dehydration and stroke in sub-Saharan Africa, help establish a sustainable system for clinical research and stroke care in Zambia, and inform a future international trial of rehydration after stroke. Given the high stroke rates and projections that stroke burden in sub-Saharan Africa will continue to substantially increase in coming years, interventions are urgently needed to improve patient outcomes in these countries. Such an intervention should be scalable and feasible to administer in non-tertiary settings, with minimal resources, and by non-physician healthcare workers. Emerging evidence indicates that early rehydration after stroke could be such an intervention.

Public health relevance
PROJECT NARRATIVE Current US stroke guidelines recommend adequate hydration as part of standard of care for individuals with stroke since dehydration appears to be linked to poor clinical outcomes. How to implement this guideline in resource-limited settings is unclear considering that prior studies implementing US-based hydration strategies for children with malaria in sub-Saharan Africa showed markedly worse outcomes. This study seeks to understand hydration status and clinical outcomes in Zambian stroke patients and will explore heterogeneity in rehydration practices to gather data to inform a clinical trial to develop locally relevant post-stroke rehydration guidelines.